Neighborhoods, Networks, and the HIV Care Continuum among HIV-infected MSM in NYC

Abstract
Marked disparities by race/ethnicity exist in HIV infection rates and engagement and retention in care
among men who have sex with men (MSM) along the HIV care continuum. Compared with White MSM, HIV-
infected Black and Hispanic/Latino MSM are less likely to be on antiretroviral therapy (ART), adhere to ART,
and achieve viral suppression. Lower rates of care engagement and retention among Black and Latino MSM
are influenced by factors beyond the individual. In order to uncover the neighborhood- and network-involved
pathways that produce racial/ethnic disparities in HIV care outcomes, yielding an empirical basis for
interventions and policies to fill gaps in the care continuum among Black and Latino MSM, systematic, theory-
based investigation of the specific and intersecting neighborhood and network characteristics that relate to
retention in care, ART adherence, and viral suppression must be engaged.
Using socioecological and intersectional conceptual frameworks, several mid-range and micro social
and psychological theories, and informed by our NIH/NIMH R56-funded formative research, we propose to
identify neighborhood-and network-level characteristics associated with HIV care continuum outcomes (viral
suppression, retention in care, and ART adherence) among 550 HIV-infected MSM living in New York City
(NYC) via a longitudinal study. We will investigate the influence of neighborhood composition and four
neighborhood-level characteristics domains, testing theoretical pathways of influence across the different
neighborhoods in which MSM live, socialize, and receive HIV care.
The Specific Aims are, among HIV-infected MSM in NYC:
Aim 1: To use spatial analysis to characterize clustering and spatial trends in HIV care outcomes.
Aim 2: To examine HIV care outcomes by race/ethnicity in relationship to longitudinal changes in: 2a)
Exposure to neighborhoods of potential influence (home; social; health facility access); 2b) Neighborhood
characteristics conceptual domains (community violence/physical disorder/social disorganization; AOD use
factors; social norms; community resources); 2c) Social networks.
Aim 3: To use multilevel modeling to assess associations among changes over time in exposure to the
neighborhood characteristics and changes in social networks with HIV care outcomes by race/ethnicity, while
assessing the potential mediating and moderating effects of individual- and network-level factors.
The study will employ an innovative approach combining geospatial mapping of neighborhoods with
multilevel modeling, spatial statistics, and an existing, extensive geospatial database. It will have direct
implications for the design of multilevel interventions, addressing factors at the neighborhood-, network-, and
individual-levels, to improve HIV care outcomes for MSM, particularly for Black and Latino MSM.

Public health relevance
Project Narrative The study purpose is to examine the neighborhoods in which HIV-infected men who have sex with men (MSM) in New York City live, socialize, and get HIV medical care and the structure and make-up of social networks (connections between friends, family members, etc.) over time, and to assess the relationship of these characteristics to achieving undetectable HIV viral load, being retained in HIV care, and adhering to HIV drugs. The study will also examine how these factors differ by race/ethnicity. This study will have direct impact on the design of programs to improve HIV care among MSM, particularly for Black and Hispanic/Latino MSM.